Intracranial Recording and Stimulation of the Human Hippocampal-Amygdala Circuit During Virtual Reality Fear Conditioning

PROJECT SUMMARY/ABSTRACT
Anxiety disorders, including generalized anxiety disorder (GAD) and post-traumatic stress disorder (PTSD), are
the most prevalent mental health conditions globally with a high rate of treatment resistance and substantial
healthcare costs. These disorders are believed to stem from fear responses that are excessive and
disproportionate to the situation. Therefore, understanding how the human brain processes fear and how this
may go awry in anxiety disorders is crucial for developing effective therapies. Research using rodent models of
anxiety suggests that the formation and regulation of fear responses to the environment require a complex
interplay between two brain structures, the amygdala and hippocampus. However, it is unknown whether these
findings can be translated to the human brain, and whether modulating neural activity associated with
maladaptive fear responses can be used as a therapeutic tool to treat anxiety disorders. This project aims to 1)
elucidate the neural mechanisms governing the acquisition, extinction, and renewal of fear and anxiety
responses within the hippocampal-amygdala circuit in humans, 2) investigate whether targeted stimulation of
the amygdala, aimed at dampening its role in maintaining fear responses to innocuous stimuli, can facilitate
recovery from maladaptive fear responses, and 3) explore potential differences in outcomes based on
individuals’ baseline anxiety levels. To address these questions, we will work with participants who have
previously undergone surgical implantation of a responsive neurostimulation (RNS) device in the amygdala
and hippocampus for the treatment of epilepsy or PTSD. The RNS is a chronically implanted intracranial
recording and stimulation device that provides a unique opportunity to directly record from the hippocampal-
amygdala circuit and deliver targeted stimulation. To simulate real-world fear responses and assess the impact
of environmental context on fear learning, we designed a virtual reality (VR) experiment where participants
acquire and subsequently extinguish fear responses to various stimuli within different virtual environments
(e.g., library, grocery store), providing insights into how contextual cues influence fear responses.
This award will allow me to complete a multifaceted career development plan under a world-class mentoring
team. Building upon my prior experience with acutely implanted intracranial electrodes, I will broaden my skill
set to encompass mobile (chronic) intracranial electrophysiology and targeted electrical stimulation. I will also
develop expertise in the implementation of immersive, ambulatory VR experiments in human neuroscience
research. Lastly, through seminars, coursework, and conferences, I will develop both as an experimental
scientist and scientific communicator. Taken together, this will allow me to grow into an independent physician-
scientist who effectively leverages innovative technologies to study the mechanisms of anxiety disorders.

Public health relevance
PROJECT NARRATIVE Anxiety disorders such as generalized anxiety disorder and post-traumatic stress disorder are the most prevalent mental health conditions worldwide and are associated with high rates of treatment resistance, disability, and significant healthcare expenses. Studying the basic neural mechanisms of fear and anxiety in humans is crucial for gaining deeper insights into the development of anxiety disorders and pioneering novel therapeutic interventions. Working with individuals who are already implanted with intracranial electrodes for epilepsy or PTSD, our research will employ virtual reality experiments to study the neural correlates of fear and investigate whether direct stimulation of the fear circuitry can ameliorate anxiety-related behaviors, thereby paving the way for innovative neuromodulatory treatments for anxiety disorders.